Administrative Supplement to Training Grant in Genomic Analysis and Interpretation for Hosting 2021 NHGRI Research Training and Career Development Annual Meeting

Abstract The NHGRI Research Training and Career Development Annual Meetings are a venue for trainees supported by NHGRI in the fields of genomic sciences, genomic medicine, and ethical, legal and social implications (ELSI) of genomics to present their research and form collaborations with other trainees and with established scientists from training programs across the United States. This application is a proposal to host the 2021 Meeting. We plan to hold the meeting April 18-20, 2021, at the UCLA Meyer & Renee Luskin Conference Center, Los Angeles, CA. This is the same venue where we successfully hosted the 2018 NHGRI Research Training and Career Development Annual Meeting. The planning and format for the proposed 2021 meeting will be substantially similar to the arrangement that proved effective in 2018.

Public health relevance
Narrative Genomics is a major driving force for modern biomedical research, and it is critical to train the next generation of experts in genomic sciences, genomic medicine, and ethical, legal and social implications. The proposed training meeting will create a large, diverse, multi-disciplinary community of trainees and researchers, and provide them career development and research training, and an opportunity to present their research and form collaborations with other trainees and established scientists from training programs across the United States.